The relationship between social needs and primary care use after enrollment in Virginia’s Medicaid expansion: The influence of sociocultural and built environments

Project Abstract. Medicaid expansion is a critical antipoverty tool that protects individuals from health care
costs and reduces food and housing insecurity, significant contributors to poor health and health disparities.
Medicaid expansion increases access to primary care, a hypothesized mechanism by which this public
insurance coverage for low-income individuals reduces social needs. However, social needs and access to
primary care are influenced by the sociocultural and built environments as well as health care system supply.
This study applies the NIMHD’s Research Framework to understand how these domains of influence
differentially shape access to primary care across those with or without social needs and in turn explores a
possible mechanism in which Medicaid expansion reduces food and housing insecurity, primary care use.
This work will leverage a well-established state-university partnership and unique data set consisting of the
experiences of newly enrolled Medicaid expansion members in Virginia. The following existing data will be
linked for this study by Medicaid member identification number: 1) pre-enrollment surveys asking members
about their experiences in the year prior to Medicaid expansion enrollment (n=1,255), 2) a follow-up survey
asking members about experiences in the year after enrollment (n=580), 3) all encounter and pharmacy claims
data for these same Virginia Medicaid members, and 4) publicly-available measures of sociocultural, built
environment, and health care system domains of influence linked to members’ census tracts or counties. The
proposed research is supported by Virginia Medicaid as it aligns with the agency’s commitment to advance
health equity through increasing primary care and reducing social needs. This proposed work aims to: 1)
Assess how sociocultural environment, built environment, and health care system domains modify the effect of
food and housing insecurity in the year prior to Medicaid expansion enrollment on primary care utilization in the
year after enrollment, and 2) Explore whether primary care utilization reduces food and housing insecurity after
the first year of enrollment in Medicaid expansion. Ultimately this work will provide much needed evidence to
policymakers about the disparities in access to primary care across sociocultural and built environment factors
as well as provide insight into how Medicaid expansion is reducing social needs. Addressing social needs
through health care policies and primary care system design will improve population health and is necessary to
achieve health equity. This application describes an excellent research and training environment for the
proposed work, supported by a collaborative mentorship team that includes both faculty members and Virginia
Medicaid’s Chief Medical Officer. This proposal will provide integrated, robust clinical and research training in
health disparities, health policy, and geospatial statistics to a physician-scientist dedicated to practicing family
medicine and pursuing a faculty position focused on advancing health equity through health policy.

Public health relevance
Project Narrative. Medicaid expansion increases health care access and reduces food and housing insecurity thus improving health and providing a tool to reduce health disparities. This project links Medicaid member claims, pre-post survey data, and community-level public health data to examine how access to primary care during the first year of enrollment is modified by sociocultural, built environment, and health care domains of influence as well as whether primary care use reduces social needs one year after enrollment. Results will help state Medicaid agencies formulate policies to reduce social needs and more equitably improve health.